Basic Research Support for the CCR

The Basic Research Program (BRP) provides scientific and technical expertise to NCI's Center for Cancer Research (CCR) in areas ranging from cancer and human immunodeficiency virus (HIV)/acquired immunodeficiency syndrome (AIDS), to the basic cellular processes underlying cancer, infectious diseases, and autoimmune disorders. There are 10 CCR research programs supported by the BSP: 1) Basic Research Laboratory - research on the cellular, molecular, genetic, biochemical, and immunological mechanisms affecting the progression, diagnosis, and treatment of cancer 2) Cancer and Inflammation Program - studies focus on how innate resistance and adaptive immunity participate in oncogenesis and tumor surveillance 3) Chemical Biology Laboratory - discovery of new small molecules, peptides, macromolecules, arrays and materials that impact cancer and AIDS diagnostics and treatment 4) Gene Regulation and Chromosome Biology Laboratory - uses a variety of organisms to investigate chromosome dynamics and regulation 5) HIV Dynamics and Replication Program - studies in structural biology, biochemistry, virology, virus-host interaction, evolution, and in vivo virus biology to better understand mechanisms of retroviral replication 6) Macromolecular Crystallography Laboratory - investigates systems and techniques relevant to macromolecular crystallography and its applications 7) Molecular Targets Laboratory - an interdisciplinary, collaborative, team-oriented approach to identifying and validating potential cancer-pertinent targets 8) Mouse Cancer Genetics Program - uses molecular mouse genetics as a primary tool to better understand the fundamental processes underlying mammalian development and disease 9) Structural Biophysics Laboratory - solution structural biology and biophysics aimed at understanding and regulating the mechanism of action of proteins and nucleic acids 10) Urologic Oncology Branch - discovery and characterization of renal carcinoma susceptibility genes